Pathophysiology of KCNQ2-related Disorders

SUMMARY | Pathogenic variants in KCNQ2 are among the most commonly discovered genetic etiologies of
neonatal and infantile onset epilepsy. KCNQ2 encodes the voltage-gated potassium (KV) channel KV7.2, which
forms hetero-tetrameric complexes with the related channel KV7.3 to generate M-current, a voltage-gated, slowly
activating and deactivating current widely distributed in central and peripheral neurons. Activation of M-current
at subthreshold membrane potentials opposes cell depolarization by incoming stimuli and dampens neuronal
excitability. The clinical spectrum of KCNQ2-related disorders ranges from self-limited familial neonatal epilepsy
(SLFNE) to sporadic cases of severe developmental and epileptic encephalopathy (DEE). It is not known why
DEE patients suffer long-lasting intellectual and developmental disabilities, while SLFNE patients have normal
neurodevelopment. This gap in knowledge hinders deployment and timing of optimal therapies. Current thinking
posits that SLFNE patients harbor mutations that cause loss-of-function and haploinsufficiency, whereas DEE
patients harbor mutations that exert dominant-negative effects or rarely gain-of-function. However, this inference
does not fully explain the heterogenity in clinical outcomes. This is likely because this it is based on work in
heterologous systems solely examining the effects of Kv7.2 mutations on channel function without considering
the impact on trafficking, localization, and differential assembly of KV7.2 channels with other KV7 subunits in
neurons. The objective of this proposal is to determine how KCNQ2 mutations impair the assembly and
physiology of neuronal KV7 ion channels. We will utilize our multidisciplinary expertise and established toolbox
of high throughput technologies and orthogonal cell models, including unique patient-specific induced pluripotent
stem cell (iPSC) derived neurons and unique mouse models, to advance understanding of pathophysiological
mechanisms that drive divergent phenotype severity in KCNQ2-related disorders. In Aim 1, we will employ our
unique, large collection of patient-specific iPSC lines with heterozygous pathogenic KCNQ2 variants to
determine drivers of phenotype divergence in this disorder, to assess trafficking and localization of mutant KV7.2,
and to determine the subunit composition of KV7 channels in human neurons. In Aim 2, we will extend our
investigations of channel composition in vivo using an existing portfolio of genetically engineered mice that
express epitope-tagged endogenous KV7 channels subunits in brain. We will determine if pathogenic KV7.2
variants disrupt the normal time, region and cell type dependent formation of KV7 channel complexes. Finally in
Aim 3, we will investigate the functional and pharmacological properties of pathogenic KCNQ2 variants when
co-expressed with KV7.5, and determine if KCNQ2-DEE variants differ from KCNQ2-SLFNE variants in their
responses to intracellular PIP2, a major regulator of neuronal M-current. Collectively, our work will fill fundamental
gaps in our understanding of Kv7 channel diversity and the impact of pathogenic variants, and inform therapeutic
strategies that seek to modify KCNQ2 patient outcomes.

Public health relevance
PROJECT NARRATIVE This proposal will advance understanding of molecular mechanisms of epilepsy, one of the most common neurological disorders affecting children and adults. The focus of the study is on a group of related potassium channel encoding genes that are prevalent causes of early childhood epilepsy and neurodevelopmental disorders and are important targets for pharmacological treatments of epilepsy. Advanced knowledge of the mechanisms by which these genes cause epilepsy will lead to improved outcomes for children with such disorders and direct the development of better anti-epilepsy drugs.